Molecular mechanisms regulating cranial sensory development

Project Summary
Worldwide, more than a third of congenital birth defects are classified as craniofacial disorders. These
disorders present diversely, from abnormal formation of facial features such as the jaw or palate, to impaired
sensory function. Despite advances in surgical reconstruction, there is still a poor understanding of the
molecular pathophysiology that underlies distinct phenotypes. Four multipotent cell lineages are the precursors
to all craniofacial cell types, forming in an anterior region of the embryo known as the neural plate border. The
central-most lineages— pre-placodal and neural crest— are especially key to craniofacial development, with
pre-placodal cells giving rise to supporting and sensorineural cell types, while neural crest cells become the
neurons and glia of the peripheral nervous system and the bones and cartilage of all facial structures. Yet
identifying the factors responsible for the initial segregation of pre-placodal and neural crest lineages has been
difficult, given that the two populations intermingle closely. This study thus aims to use a genetic lineage-
tracing approach to isolate the pre-placodal and crest lineages and investigate the roles of two candidate
molecules in pre-placodal specification. Our lab previously discovered that the Foxi3 transcription factor is
transiently expressed in border cells and that genetic deletion of Foxi3 primarily affects placode-derived
structures, including loss of the inner ear. Preliminary lineage tracing with a Foxi3CreER conditional reporter
mouse line generated in the lab revealed that normal Foxi3-expressing border cells mostly become placode
derivatives, but some mutant cells take on alternative border lineage fates. From this data, we hypothesize that
Foxi3 directly specifies the pre-placodal lineage. We will test this hypothesis by further analyzing the fate of
Foxi3 mutant border cells, using lineage tracing with our Foxi3CreER mice. We will also use a single-cell
multiomic approach to assess concurrent transcriptional and epigenetic changes in Foxi3 functionally null
border cells. Extracellular signaling also influences border lineages: notably, BMP signals are known to induce
neural crest cells. Given the similar BMP levels to which crest and pre-placodal cells are exposed, we
hypothesize that BMP also affects placode cell specification. We will test this hypothesis by an in vivo, genetic
manipulation of BMP targeted to pre-placodal (Foxi3CreER) versus crest (Zic5CreER) border cells. Our work
introduces the first method to isolate and study the mammalian pre-placodal lineage and will shed light on
critical factors that direct neural plate border cell fate. We will also gain insight to molecular changes that
facilitate fate transitions at the border, with the potential to identify genes whose mutation could result in
specific kinds of disruption to craniofacial development.

Public health relevance
Project Narrative The complex sensory and structural defects of craniofacial disorders can be traced to an early period in embryogenesis, with the emergence of four multipotent cell lineages at the neural plate border. Of these four, the neural crest and pre-placodal lineages are most closely-related, respectively forming all facial bones and cartilage, as well as cranial sensory organs and nerves, in parallel. The goal of this project is to expand our knowledge of the distinct molecular mechanisms that govern placodal and neural crest progenitor fates by examining novel roles for the Foxi3 transcription factor and extracellular BMP signaling during border cell specification.